Tau-RNA crosstalk: Alternative Poly-Adenylation (APA) Regulation in Alzheimer's Disease

Alzheimer's disease (AD) is a devastating degenerative brain disorder and the most prevalent form of
dementia, affecting millions worldwide. Given its significant impact on public health, it is crucial to accelerate the
development of treatments that would prevent, delay, or reverse the course of the disease and improve early
diagnosis. In neurons, Tau protein is primarily known for its canonical role in assembling and stabilizing
microtubules. Moreover, native Tau binds to both DNA and RNA molecules, suggesting a role in RNA
transcription, post-transcriptional processing and translation. However, in the AD brain, Tau protein undergoes
misfolding and subsequently forms pathological oligomers. In this context, I propose that misfolded Tau is unable
to bind RNA, hampering its function on RNA post-transcriptional processing and altering gene expression.
One of the key mechanisms for controlling gene expression in eukaryotic cells is Alternative Poly-
Adenylation (APA). APA can affect the length, stability, translation, localization, and function of mRNAs. In our
inducible Tau cell model, wild-type or native (wt) Tau modulates the expression of several APA mRNAs that
encode RNA-Binding Proteins (RBPs). Several of these identified RBPs have been observed with altered
function and aggregation in AD and Frontotemporal lobar degeneration (FTLD). These findings underscore the
substantial involvement of APA in neuronal degeneration, highlighting its paramount significance in
the pathogenesis of AD and AD related disorders (AD/ADRD). However, the mechanism underlying how
Tau modulates APA is unknown. We propose that in AD, Tau oligomerization interferes with APA and
hampers short and long 3'-UTR mRNA isoforms of RBPs critical to RNA processing.
The primary outcome of this study is to comprehensively profile APA transcripts and gene expression in wild
type and mutant Tau-expressing neurons. We seek to build upon our published data, investigating the
effects of pathological Tau (oligomeric and mutant forms) on APA, which is yet to be determined. We will test
our hypothesis via two specific aims. In Aim 1, our objective is to identify and compare mRNA isoform libraries
from mouse primary hippocampal neurons expressing human wt-Tau (htau) and pathogenic mutant
Tau (rTg5410, MAPT-P301L). We are excited to harness the groundbreaking Poly(A)-ClickSeq (PAC-
Seq) technology, an innovative approach that will unlock comprehensive profiles of APA transcripts and
gene expression in wt and mutant Tau-expressing neurons. In Aim 2, we propose to identify APA mRNA
isoforms in htau and rTg4510 before and after the manifestation of Tau pathology. Additionally, we will use
biochemical and cellular assays to pinpoint changes in Tau oligomer-modulated mRNA isoform levels and
expression. Our approach delves deeper into the impact of APA, surpassing the limited evaluation of gene
expression offered by previous RNA-Seq methods. By connecting APA with Tau pathology, our study seeks
to advance the field by identifying the mRNA isoforms altered by pathological Tau in AD/ADRD.

Public health relevance
The proposed research is relevant to public health because it focuses on identifying key alternative poly- adenylated mRNA isoforms underpinning the detrimental action of pathological tau oligomers that characterize various tauopathies including Alzheimer’s disease (AD) and AD related dementia (ADRD). This is ultimately expected to drive the development of a novel, effective preventive/curative therapy for AD and tauopathies, thus improving patients’ health while driving down the societal cost for their care, which is expected to increase to unbearable proportions by the year 2050. Thus, the proposed research is relevant to the part of NIH’s mission concerned with fostering creative discoveries by new generation of neuroscientists, and their application to advance the nation’s capacity to protect and improve human health.